Neuro-Optical Diagnostic System for Macular Degeneration

NeuroFieldz is pursuing commercialization of NeuroDotVR, a portable wireless diagnostic system for neuro-
visual disorders. The company is currently working on a Phase II SBIR project on early diagnostics for Macular
Degeneration. NeuroFieldz has developed a carefully conceived commercialization plan to translate the
NeuroDotVR technology to the marketplace.
NeuroFieldz was recently the subject of a Needs analysis commissioned by NIH, that identified the strengths and
weaknesses of the company. A central conclusion of the analysis was that while the company was strong in its
technical portfolio, several steps needed to be implemented in order to make the company attractive to investors.
This TABA supplemental request addresses some of the key next steps through the following tasks:
Task 1: Develop detailed business and financial plans and forecasts.
Task 2: Develop a detailed Valuation and Equity Strategy.
Task 3: Develop strategic partnerships.
This TABA supplemental project will enable NeuroFieldz to develop a strong business plan based on sound
financial projections, create an investment and equity strategy that will attract equity investments, and establish
key partnerships to accelerate commercialization.

Public health relevance
PROJECT NARRATIVE TITLE: Neuro-Optical Diagnostic System for Macular Degeneration This project seeks to develop a new portable wireless system called NeuroDotVR that combines a sensor for measurement of scalp electric potentials and fields during recovery from dark adaptation using visual stimuli presented by a virtual reality headset powered by a smartphone, and to test them in patients with Age-related Macular Degeneration (AMD). NeuroDotVR will address an unmet need for a practical, sensitive test that will provide quantitative endpoints for early diagnosis and monitoring response to newly developed treatments for AMD.